High Throughput Biology Core

HIGH-THROUGHPUT BIOLOGY CORE – ABSTRACT
The High-Throughput Biology Core will support Project Teams with target-based and phenotypic high-throughput
screening (HTS) campaigns to identify diverse tractable chemical matter and SAR (structure-activity
relationship)-enabling primary dose-response assays for lead identification and optimization efforts. This will be
achieved in close collaboration with the Virology Core (providing molecular target hypothesis and develop BSL2
suitable vectors for translatable in vitro phenotypic assay systems) and the Drug Discovery Core (helping to
design tailored screening sets for iterative HTS and providing medicinal chemistry support to enable lead
identification and optimization). The High-Throughput Biology Core, with established in-house expertise in
assay development and miniaturization, proficiency in diverse recombinant protein expression systems,
compound and data management systems, and state-of-the-art screening and automation infrastructure
including BSL2 HTS capability, will enable HTS to identify new chemical starting points for drug discovery and
also validate new targets. Further, the High-Throughput Biology Core will also enable medicinal chemistry
efforts to improve on-target potency and enhance selectivity with robust SAR-enabling primary dose-response
assays. This will facilitate the optimization of lead candidates with improved physiochemical properties having
desirable potency, selectivity and ADME properties to ultimately deliver safe and efficacious promising clinical
candidates. In summary, the High-Throughput Biology Core will enable UNAPP’s drug discovery efforts
by helping Project Teams to identify tractable diverse chemical matter necessary to validate new targets
and support antiviral drug discovery to ultimately select the best candidate for development.